Deepening optical imaging with next-generation photoacoustic computed tomography

Abstract
Deep-tissue imaging remains a fundamental challenge in biomedical optics due to light scattering, limiting high-
resolution optical imaging to depths of approximately 1 mm, also referred to as the optical diffusion limit due to
the use of ballistic or quasi-ballistic photons. Photoacoustic tomography (PAT) uniquely circumvents this limitation
by using deep penetrating diffuse light to excite photoacoustic waves, which are then detected ultrasonically,
leveraging the low scattering of sound in biological tissues to provide high spatial resolution. This proposal aims to
push the imaging depth of PAT from the current limit to 6 cm while providing high spatial resolution. Achieving this
ambition requires fundamental improvements across the entire imaging chain, from optical excitation to ultrasonic
detection and image reconstruction.
We propose the following advancements: (1) optimizing SNR by scanning laser pulses with a higher repetition
rate to satisfy both ANSI safety limits and incorporating ultrasonic excitation for accurate acoustic speed-of-
sound imaging and de-aberration, (2) enhancing ultrasonic detection by maximizing the detection solid angle and
packing density (i.e., fill factor) while providing spatial Nyquist sampling with coded masking, (3) refining joint
reconstruction augmented by ultrasonic excitation to de-aberrate acoustic blurring and tailoring motion correction
to mitigate motion artifacts over extended acquisition times, and (4) performing in vivo imaging of human breasts
to validate the proposed technology using contrast-enhanced MRI as the gold standard owing to its shared ability
with PAT to image blood vessels.
The team has achieved multiple milestones in PAT, including the first in vivo functional PAT, the first 3D pho-
toacoustic microscopy with cellular resolution, and the most widely adopted PAT reconstruction method. These
foundational contributions have established PAT as the leading high-resolution optical imaging technique in terms
of deep-tissue penetration. Despite its success, further technical breakthroughs are required to address the
challenges of providing even greater penetration.
This proposal introduces a synergistic approach by optimizing laser delivery, ultrasonic detection, acoustic de-
aberration, and advanced reconstruction algorithms to achieve a quantum leap in PAT. The proposed innovations
will significantly enhance PAT’s diagnostic potential in biomedicine, particularly in breast cancer detection, where
deep-tissue visualization is critical for early detection and treatment monitoring. The impact of this research
extends to a broad range of biomedical applications.
In summary, by systematically improving PAT from excitation to detection and reconstruction, this work will es-
tablish the next-generation PAT, capable of transforming clinical imaging. The proposed research aligns with the
long-term goal of developing PAT into a widely accessible, non-invasive imaging tool that provides greater imaging
depths with high resolution.

Public health relevance
Project Narrative Physicians and scientists face a major challenge in optical imaging because light scatters inside the body, making it difficult to see with high clarity deeper than approximately one millimeter. Our research aims to improve pho- toacoustic imaging, which uses light to create sound waves inside tissues and detect the sound to produce clear images much deeper than traditional high-resolution optical methods. By refining how light is delivered, sound is detected, and images are reconstructed, we aim to enhance this technology to detect breast cancer at even greater depths without using harmful ionizing X-ray radiation or injecting contrast agents.